Mechanisms of Complement Activation in Traumatic Injury

Project Summary
The leading cause of death from ages 1-44 years in the United States is traumatic injury, responsible for
millions of hospital encounters at a cost of over $4 trillion annually. Unfortunately, outcomes in trauma patients
who survive the initial injury have not seen the marked improvements observed in other fields of medicine
recently, so more research is critical. It is known that a key driver of delayed mortality after injury is organ
failure, where a marked inflammatory response and dynamic coagulopathy are both implicated. Approximately
1 in 4 patients who suffer from major trauma have a detectable coagulopathy on clinical coagulation testing,
and even more have a perturbation in fibrinolysis, a process mediated by the protease plasmin. A major
inflammatory signaling pathway in the blood circulation is called complement, a protease cascade that shares
a number of cleavage specificities with the coagulation system with increasing recognition the two processes
heavily influence one another. It logically follows that acute traumatic coagulopathy and inflammatory organ
failure may therefore be related processes, with complement-mediated inflammation being a key link. In
support of this, the extant literature has shown the degree of complement activation correlates with both organ
failure and mortality, but the primary mechanism of complement activation after trauma remains unknown. Our
preliminary results and prior work suggest that the observed complement activation may occur as a direct
result of plasmin cleavage of complement proteins, where plasmin is known to be generated in large amounts
in trauma patients with severe shock. In addition, we also know that after trauma the vascular endothelium
sheds its glycocalyx into the circulation, which may serve to activate complement via the lectin pathway, which
is a complement activation pathway that binds to specific glycans and causes robust complement activation.
To further elucidate the mechanism of complement activation after trauma, we are now proposing 3 Aims. In
Aim 1, we propose a focused protein and glycan biomarker investigation of plasma from human trauma
patients to test whether plasmin generation or circulating endothelial glycocalyx molecules correlate with
degree of complement activation. In Aim 2, we will use a human endothelial cell culture model designed to
mimic traumatic shock to elucidate whether plasmin, endothelial glycocalyx molecules and the lectin pathway,
or both are capable of generating robust complement activation in the absence of other complement pathways
to delineate relative contributions and mechanism of activation. Finally, in Aim 3, we will directly investigate the
role of complement in generating organ failure in trauma using a mouse model of trauma comparing mice
deficient in complement proteins C3 and C5 with wild-type mice. The results of this Aim would highlight the
potential role of anti-complement therapies for future clinical study considerations. Taken together, this
research program will improve our understanding of the mechanisms of complement activation and
inflammatory organ injury after trauma in this leading cause of death in the United States.

Public health relevance
Narrative Traumatic injury is the leading cause of death from ages 1-44 in the United States, claiming more than 200,000 lives per year and is responsible for millions of hospital encounters at an annual cost of over $4 trillion USD. While approximately half of trauma patient deaths occur early after injury from bleeding or brain injury, the other half occur in a delayed fashion and frequently are related to organ failure (lungs, kidneys) that is driven, in part, by inflammatory responses. We are performing research focused on understanding how a key inflammatory system called complement gets activated and contributes to the organ failure and delayed deaths observed after traumatic injury, which may eventually lead to novel therapeutic interventions to prevent death in these predominantly young, healthy patients who would otherwise have a long life ahead of them.